Multidisciplinary Training Program in Lung Disease

Project Summary
The goal of the program is to produce outstanding biomedical scientists who expand the
envelope of our knowledge of the mechanisms, manifestations, prevention, and cures of
lung disease. The program combines intensive training in a single area of investigation
within a multidisciplinary academic environment. The training is available at both the pre-
and post-doctoral levels, supporting 4 pre-doctoral and 14 post-doctoral trainees per
year. A PhD program may be completed in 5 years. At the postdoctoral level, qualified
MD or PhD candidates complete 2 or more years of training. A wide range of training
opportunities are provided by a large interactive network of faculty supported by
individual, collaborative and inter-institutional research grants. These opportunities
include lung-related research in behavioral science, cellular and molecular biology,
environmental science, clinical trials, epidemiology, global health, immunology and
infection, airway biology, sleep biology and vascular biology. The core of the experience
is the close relationship between a primary mentor, co-mentors and the trainee. This is
supplemented by individual development plans, formal course work, core conferences,
training in responsible research conduct, communication skills, career planning, and
grant writing. Postdoctoral trainees in the clinical sciences can acquire a Masters or
Doctoral degree. Fellows and mentors are reviewed by a committee that monitors the
training and career development of fellows, and promotes mentoring skills. Doctoral
students are reviewed by a thesis committee that provides both support and guidance.
Over 15 years, 85% of graduates take 3 or more years of training supported by 56
individual F32 NRSA awards, and 95% of graduates take full-time academic positions
after graduation. Our graduates have been awarded 47 mentored K awards, and 19
other non-government career development awards. Thus, the program has met its goal
to train the next generation of leaders in lung research.

Public health relevance
Project Narrative Lung disease is a leading cause of death and disability in the United States. Despite an expanding understanding of the causes of lung disease, treatments that cure these disorders are lacking and most treatments are symptomatic or supportive. The goal of this program is to train highly qualified individuals in the research disciplines that are necessary to find better treatments for these disorders.